5HT AND NE IN AGGRESSION AND SUICIDE IN PERSONALITY DISORDER

This protocol addresses the hypothesis that disturbances of the serotonergic and noradrenergic systems interact in the expression of impulsive, aggressive, and/or suicidal behavior in the personality disorders and major depressive disorder (MDD).